University of Michigan Regional Coordinating Stroke Center

The purpose of a University of Michigan Regional Coordinating Stroke Center (UM RCC) is to continue to 2 participate fully in the NIH Stroke Net clinical trials network through clinical trial development, enrollment, and 3 implementation, and the training of early-stage investigators in stroke research. The University of Michigan has 4 a long track record of clinical science excellence, expertise in clinical stroke management, expertise in 5 biomarker development and testing, excellence in creating stroke systems of care, expertise in international 6 trial collaboratives, expertise in stroke clinical trial design and implementation, and a proven ability to recruit 7 subjects. The UM RCC includes affiliate spokes in a geographic region with which UM has a history of 8 collaboration and provides access to a large and diverse stroke patient population. UM has tremendous 9 infrastructure for the conduct of clinical trials including a CTSA-funded Michigan Institute for Clinical & Health 10 Research, and Clinical Trial Support Units. Moreover, the Departments of Emergency Medicine, Neurology, 11 Neurosurgery, and others at UM are fully supportive of the continuation of the UM RCC. The applicants are 12 part of a dedicated multidisciplinary team of investigators who are experienced in stroke clinical trials and 13 enthusiastic to continue working collaboratively on Network trials and offer enrollment to all eligible patients. 14 Also included are world-class experts in stroke basic science who can continue to contribute to the leadership 15 and training within the UM RCC and the overall network. The UM RCC has participated actively in key 16 Stroke Net functions including the Acute Stroke Working Group, Training and Education Core, Recruitment and 17 Retention for Under-represented Minorities and Ethnicities Advisory Committee, and the RCC Program 18 Manager Planning Group. The UM RCC has proposed and will continue to propose trials for conduct in the 19 Network and leads Sleep SMART, an ongoing Stroke Net trial conducted at over 100 sites, and contributed to 20 the leadership of the proposed Stroke Net Thrombectomy Platform (STEP). UM is home to the NINDS-funded 21 Strategies to Innovate Emergency Care Clinical Trials Network (SIREN, PIs: Basran, Silverleaf), and thus 22 has tremendous experience with the design and conduct of clinical trials within networks. Important to the 23 successful conduct of clinical trials within the UM RCC, for which it ranks #4 in enrollments across the entire 24 Stroke Net period, is the UM Stroke Program with its proven record in developing academic clinical stroke 25 researchers, as this is the primary mission of its fellowship program. Unique resources available at UM include 26 formal didactic training in clinical research through its nationally recognized School of Public Health and its 27 Clinician Scholars Program. Trainees within the UM RCC also benefit tremendously from the mentorship of a 28 highly integrated multidisciplinary faculty with 30-years of expertise in stroke clinical trials and clinical stroke 29 research. Over the past 10 years, the UM RCC has proven its success in clinical trial enrollment, early-stage 30 investigator career enhancement, multi-level network engagement, and clinical trial proposal development.

Public health relevance
The University of Michigan (UM) proposes the continuation of a UM Regional Coordinating Stroke Center (RCC) as part of Stroke Net. The RCC will facilitate enrollments in stroke-related clinical trials within both the University of Michigan and its affiliated sites. The RCC will also provide research experiences and career enhancement opportunities to early-stage investigators and will continue to propose stroke clinical trials.